Novel unconventional myosins in B cell homeostasis

ABSTRACT
Incurable autoimmune diseases afflict millions of Americans, cause pain and persistent damage to multiple organ
systems, and have a major impact on patient health, well-being and quality of life. Increased B cell numbers,
greater B cell activation and differentiation into plasma cells, and autoantibody production often characterize
autoimmunity, signifying that dysregulated B cell survival and differentiation are critical steps in autoimmune
pathogenesis. Identification of proteins and molecular events that regulate B cell survival, activation and
differentiation is therefore critical for better mechanistic understanding of autoimmune disease
development. Myo18A is a scaffolding protein with a unique domain organization that enables assembly of
multiprotein complexes in various subcellular compartments of non-immune cells. We reported that B cells
express Myo18A, and that its conditional deletion in B cells (Myo18A BKO) leads to an increase in mature B
cells and plasma cells, splenomegaly, hypergammaglobulinemia, and development of autoantibodies.
Interestingly, this profile overlaps with autoimmune manifestations reported in transgenic mice overexpressing
the B cell survival factor BAFF, and in mice with genetic deletion of proteins involved in mRNA decay. In
preliminary data, we observed that Myo18A-deficient B cells display features of greater BAFF responsiveness,
including increased mitochondrial size and gene expression, and stronger pro-survival Akt signaling, indicating
that Myo18A negatively regulates B cell response to BAFF. Additionally, deletion of Myo18A in B cells increased
the basal expression and reduced the decay of mRNA encoding Blimp-1, a key transcription factor in B cell
differentiation. Further, Myo18A in B cells bound to Blimp1 mRNA and co-localized with subcellular mRNA
degradation sites, indicating that Myo18A is involved in post-transcriptional regulation and expression of Blimp-
1. Our published and preliminary data suggest that Myo18A is an important and previously unrecognized
determinant in B cell immunity. Our specific aims are to test the hypotheses that (1) Myo18A restricts BCR
and BAFF-R signaling to control B cell homeostasis, (2) Myo18A inhibits mRNA stability to inform B cell gene
expression, and (3) Myo18A limits B cell differentiation by controlling the B cell transcriptome. The proposed
research is innovative because it will establish a novel role for the unconventional myosin family protein Myo18A
in preventing uncontrolled B cell activation and differentiation. Specifically, our research will identify a novel
functional connection between Myo18A and B cell survival and differentiation through regulation of B cell antigen
and BAFF responsiveness and post-transcriptional mRNA stability. This research is expected to have
significant impact because it will enable better mechanistic understanding of the molecular processes that
prevent exaggerated antibody development.

Public health relevance
PROJECT NARRATIVE Life-threatening and incurable autoimmune syndromes affect millions of Americans and are often associated with exaggerated B lymphocyte activation and differentiation, and generation of self-reactive antibodies, which cause pain and damage in various parts of the body. In this application, we propose to investigate a novel role for an unconventional myosin family protein in regulating B cell homeostasis and antibody production. Insights from our study will reveal novel molecular mechanisms that control B cell function to prevent autoimmunity.